Mechanisms of Cell Regulation and Manipulation by the Ubiquitin System

Eukaryotic cells have highly conserved enzymatic systems for covalently linking ubiquitin (Ub)
and related proteins such as SUMO to proteins. The modifications may lead to degradation of the
targeted protein, usually by the proteasome. Ub and SUMO modifications are highly dynamic due
to specialized proteases that efficiently remove them. Both modifiers have many crucial roles,
including important contributions to human biology. Many human disorders, including
neurodegenerative diseases and different cancers, are associated with abnormalities in the Ub
system. Multiple drugs that target the Ub system are already in the clinic.
In this renewal, the PI proposes to undertake studies on several recently discovered regulatory
mechanisms. One focus is on the assembly and intracellular trafficking of proteasomes, which
normally concentrate in the nucleus but undergo dramatic relocalization and changes in assembly
when grown in specific nutrient-limited conditions. A key mechanism may be the regulated Ub-
independent degradation of a transport adaptor that controls proteasome translocation into the
nucleus. Another research direction addresses Ub-system enzymes secreted by endosymbiotic
bacteria that infect humans and other species. One target is a deubiquitylating enzyme (DUB)
from Orientia tsutsugamushi, the causative agent of scrub typhus, a highly lethal disease. Small-
molecule inhibitors are being developed to antagonize the Orientia DUB. Another important DUB
is from Wolbachia, bacteria that infect millions of arthropod species and exploit this unusual DUB
to alter host reproduction to promote their own inheritance. A related system utilizes a nuclease
to similar effect, which will also be investigated. Wolbachia are being deployed as agents for
fighting disease vectors such as the mosquitoes that transmit dengue fever and malaria.
Regarding SUMO protease functions, several new directions are being followed. One derives
from a discovery that, following in vitro evolution, a mutation in yeast SUMO greatly mitigates the
loss of a crucial SUMO protease. Another mutation at the same position blocks all SUMO
cleavage. Initial data indicate that the inability to tolerate loss of SUMO cleavage is linked to
thiamine (vitamin B1) deficiency. A final area of focus is on the question of why Ub, SUMO, and
almost all other Ub-like proteins (Ubls) are synthesized with C-terminal extensions that must be
removed. Potentially, tail cleavage serves as a proofreading step to prevent aberrant forms of the
Ubl from getting attached to targets. Overall, the combination of genetic, biochemical, cell
biological, and genomic studies proposed should give a much deeper understanding of the
mechanisms of SUMO and Ub pathway regulation with important implications for human health.

Public health relevance
A small protein called ubiquitin (and a family of related proteins) regulates the growth, division, and behavior of all human cells and those of all organisms with a nucleus. Ubiquitin is physically attached to specific proteins, and this often induces the degradation of the tagged protein; defects in the enzymes controlling these processes cause human neurodegenerative disorders, developmental abnormalities, and many cancers. This project aims to deepen our understanding of enzymes regulating the attachment of ubiquitin and related proteins to their targets and of how the proteasome degrades ubiquitin-tagged proteins, with the long-term goal of developing therapies to treat patients suffering from neurodegenerative disorders, diabetes, cancer, and certain infectious diseases.